Mitochondrial DNA Repair and Biogenesis

DESCRIPTION (provided by applicant): This is an application for a career development award to establish the PI with advanced training in molecular physiology in preparation for a career as an independent investigator in the area of sepsis-related organ failure. The PI will investigate the role of the mitochondrial DNA repair (mDNA) enzyme, OGG1 and nuclear coactivators, PGC-11 and its family members, in mtDNA maintenance and biogenesis in a murine Staphylococcus sepsis model. MtDNA is a critical target of oxidative and nitrosative damage from cytokine and chemokine release, and mitochondrial biogenesis is one of the critical repair mechanisms. My overall working hypothesis is that the maintenance of adequate mitochondrial function in sepsis requires nuclear coordination of an integrated program of mtDNA repair and mtDNA replication in order to ensure fidelity of mtDNA transcription and for mitochondrial biogenesis given that sepsis leads to mtDNA damage by reactive oxygen species and reactive nitrogen species. If this mtDNA damage from sepsis exceeds the cell's ability to repair damaged mtDNA, fewer mitochondrial genomes will be available for transcription; this inflammatory insult will decrease the cells' capacity for oxidative phosphorylation. The cell either accommodates to this change in functional mtDNA equilibrium through mitochondrial biogenesis, or the cell will undergo death by either necrosis or apoptosis. Therefore, I hypothesize that enhanced mtDNA repair in sepsis is a prerequisite for mitochondrial biogenesis to avert the energy failure that would lead to organ injury. This hypothesis will be tested with the following specific Aims: Specific Aim 1: Understand the role of OGG1 in maintenance of mtDNA copy number during Staph aureus sepsis in mice. Specific Aim 2: Identify the critical nuclear co-activator for NRF-1-induced Ogg1 gene expression in gram positive sepsis and sepsis-related inflammation. Specific Aim 3: Understand the importance of the AMP-kinase pathway activation in sepsis as it relates to nuclear co-activator function and mtDNA repair enzyme induction. The completion of these Aims will improve our understanding of the role of mtDNA damage and repair in severe sepsis and in protection from organ failure that would lend itself to the development of novel prognostic and therapeutic strategies for host protection.

Public health relevance
PUBLIC HEALTH RELEVANCE: Sepsis is the 10th leading cause of mortality in the United States. Current strategies to treat sepsis beyond supportive care and antibiotics are limited. Understanding the pathophysiologic processes that lead to sepsis- induced organ dysfunction will ultimately lead to new therapeutic pathways. Sepsis is the 10th leading cause of mortality in the United States. Current strategies to treat sepsis beyond supportive care and antiobiotics are limited. Understanding the pathophysiologic processes that lead to sepsis- induced organ dysfunction will ultimately lead to new therapeutic pathways. __SpecificAimsTextDelimiter__ Research Plan A. Specific Aims: The overall goal of this career development application is to prepare the PI for an independent research career through a comprehensive program of applied molecular biology in a laboratory environment that has fostered the education of many physician-scientists. Using an established mouse sepsis model of clinical relevance complimented by relevant coursework, the PI will not only gain significant understanding of basic science but will also be well positioned for scientific independence. To develop the skills necessary for scientific independence, the PI will formally and informally interact with her Mentors and Advisory Committee. This group of highly successful mentors will ensure a program in the laboratory that is designed to give the PI broad and modern scientific skills for future investigation and to translate this investigation to the pathogenesis of human sepsis as it relates to mitochondrial biogenesis and determinants of patient survival and organ repair. Oxidative and nitrosative molecular damage in sepsis caused by the release of cytokines is thought to play a major role in the cellular response to injury in the form of mitochondrial DNA (mtDNA) damage. This mtDNA damage by reactive active oxygen and nitrogen species (ROS/RNS) can be repaired in order to maintain adequate mtDNA for mitochondrial biogenesis. Given that sepsis leads to mtDNA damage by oxidation my hypothesis is that the maintenance of adequate mitochondrial function in sepsis requires nuclear coordination of an integrated program of mtDNA repair in order to ensure high fidelity mtDNA for mtDNA replication and for appropriate mitochondrial biogenesis. If mtDNA damage induced by ROS and RNS produced during sepsis exceds the cel's ability to repair damaged mtDNA, fewer functional mitochondrial genomes will be available for transcription; this inflammatory insult wil therefore decrease the cells' capacity for oxidative phosphorylation. Decreased oxidative phosphorylation may lead to decreased intracellular energy and cell death by necrosis and/or apoptosis resulting in impaired organ function. However, organs are able to recover over time suggesting that active intracellular processes maintain mtDNA number through repair mechanisms. Therefore, I hypothesize that enhanced mtDNA repair mechanisms in sepsis is a prerequisite for mitochondrial biogenesis to avert compromise in energy availability which leads to organ injury. These hypotheses will be tested with the following three Specific Aims: Specific Aim 1: Understand the role of OGG1 in maintenance of mtDNA copy number during Staph aureus sepsis in mice. Goal: Determine the role of OGG1 in restoration of hepatic mtDNA replication and transcription, and prevention of hepatic cell death in vivo. Hypothesis: The mitochondrial DNA base excision repair enzyme OGG1 is up-regulated in response to the nitrosative and/or oxidative stress of severe infection and the repair is regulated by NRF-1 as part of a transcriptional program leading to the maintenance of functional copies of mtDNA which prevents hepatic cell death in response to S. aureus sepsis. Specific Aim 2: Identify the critical nuclear co-activator for NRF-1-induced Ogg1 gene expression in gram-positive sepsis and sepsis-related inflammation. Goal: Define the role of nuclear co-activators PGC-1α, PGC-1β, or PRC in NRF-1 dependent Ogg1 expression of mtDNA replication in response to TLR2 activation in-vivo and in-vitro. Hypothesis: PGC-1α, PGC-1β, or PRC promote OGG1 expression in sepsis-induced inflammation through co-interaction with NRF-1 and this interaction is protective against sepsis-induced oxidative stress. Specific Aim 3: Understand the importance of the Amp-kinase pathway activation in sepsis as it relates to nuclear co-activator function and mtDNA repair enzyme induction. Goal: Define the role of the AMP-kinase pathway activation in sepsis as it relates to PGC-1α, PGC-1β, or PRC interaction with NRF-1 and Ogg1 expression. Hypothesis: AMP-kinase activation, through its interaction with PGC-1α, PGC-1β, or PRC, is protective against sepsis-induced cellular dysfunction via transcriptional activation of Ogg1. The completion of these Aims wil improve our understanding of the role of mtDNA damage and repair in severe sepsis and in protection from organ failure that would lend itself to the development of novel prognostic and therapeutic strategies for host protection.